Development of SUV39H1-selective inhibitor for human colon cancer therapy

Project Summary
Only the microsatellite instability high (MSI-H) human colorectal cancer, which accounts for 10-15% of all
human colorectal cancer cases, responds to PD-(L)1 blockade immunotherapy. The vast majority (85-90%)
of human colorectal cancer is the microsatellite stable (MSS) subtype that does not respond to PD-(L)1
blockade immunotherapy. PD-(L)1 blockade immunotherapy works through blocking PD-1 function to activate
cytotoxic T lymphocytes (CTLs). The activated CTLs then target tumor cells to activate the death pathways to
induce tumor cell death. Therefore, two factors are essential for the efficacy of PD-(L)1 blockade
immunotherapy: CTLs must be activated and the target tumor cells must be sensitive to cell death induction.
Human colorectal tumor cells, especially the metastatic colorectal tumor cells, are highly resistant to cell death
induction. Literature and our published data indicate that, although MSI-H human colorectal cancer has high
level of tumor-infiltrating CTLs, CTLs are also present in the MSS human colorectal carcinoma. Our published
data further determined that tumor-infiltrating CTLs are functionally impaired in human colorectal carcinoma.
SUV39H1 is a histone 3 lysine 9 (H3K9) site-specific histone methyltransferase that catalyzes H3K9me3.
Literature and our preliminary studies determined that the SUV39H1-H3K9me3 epigenetic axis represses both
the death receptor FAS expression in human metastatic colon tumor cells and Gzmb expression in colon
tumor-infiltrating CTLs. To target SUV39H1-H3K9me3 axis, we have developed a small molecule SUV39H1-
selective inhibitor (termed F5446). We determined that F5446 is effective in: 1) decreasing H3K9me3
deposition at the FAS promoter in metastatic human colon tumor cells to increase tumor cell sensitivity to
FasL-induced cell death; and 2) decreasing H3K9me3 deposition at the Gzmb promoter to increase Gzmb
expression in tumor-infiltrating CTLs to suppress colon tumor growth in immune competent mice. To achieve
tumor-selective delivery for improved safety and efficacy, we have now developed the expansile nanoparticle
encapsulated F5446 (termed eNP-F5446). Our hypothesis is that eNP-F5446 is an effective and safe agent
for overcoming colorectal cancer resistance to PD-1 blockade immunotherapy. Three specific aims will be
pursue to achieve our objectives: 1) determine the tumor/cell/subcellular localization, trafficking, and
biodistribution of eNP-F5446 in the syngeneic mouse colon tumor liver metastasis and human colon cancer
xenograft liver metastasis models; 2) conduct pharmacokinetics and toxicology studies of eNP-F5446 in
tumor-free and colon tumor-bearing mice; 3) determine the efficacy of eNP-F5446 in overcoming human
metastatic colorectal cancer resistance to PD-1 blockade immunotherapy in vivo.

Public health relevance
Project Narrative This proposal will develop the SUV39H1-selective small molecule inhibitor F5446 nanoparticle eNP- F5446 to restore tumor cell sensitivity to cell death induction and to re-activate tumor-infiltrating CTL effector function in colorectal cancer. eNP-F5446 is expected to overcome human colorectal cancer resistance to PD-(L)1 blockade immunotherapy.